ART Modulation of Viral Pathogenesis

ABSTRACT
This is the renewal application of 5R01DE018304-15. It responds to NOT-DE-25-038 / "Basic and Translational
Oral Health Research Related to HIV/AIDS." Kaposi Sarcoma (KS) is the most common cancer in people living
with HIV today, whether in the US or in Sub-Saharan Africa, where the majority of PLWH reside. KS can form in
the oral cavity. Oral KS is considered a marker-aggressive disease. KS can occur in severe immune-
compromised people but also in PLWH, in whom ART suppresses HIV replication to below 50 copies/ml. Kaposi
sarcoma herpesvirus (KSHV) is entrenched in populations for increased risk of HIV acquisition, including
members of racial and socioeconomic minorities. Not much is known about the effect of ART on Kaposi sarcoma-
associated herpesvirus (KSHV) oral transmission, oral and systemic KS disease, or the latent KSHV reservoir.
We propose to investigate the impact of ART in the context of chemotherapy for KS and define novel disease
biomarkers. We apply advanced technologies and analytics to one of today's largest clinical trial collections to
allocate HIV+ KS patients to the best therapy for them.

Public health relevance
NARRATIVE Kaposi Sarcoma (KS) is the most common cancer in people living with HIV worldwide, including in its oral manifestation. It is caused by Kaposi sarcoma-associated herpesvirus (KSHV). This proposal is in response to NOT-DE-25-038 and will discover novel biomarkers for disease progression and therapy selection.